Lewis Base Ligands Designed to Control Carbon-Carbon Bond Formation

PROJECT SUMMARY/ABSTRACT:
The impact of synthetic chemistry on society cannot be overstated. Organic chemistry has changed our world
in momentous ways, from giving women reproductive rights through the invention of contraceptives, to creating
pesticides that allow us to feed the globe. It is axiomatic that innovations in medicine are invariably linked to
advancements in organic chemistry as most medicines are synthesized by organic chemists. It has long been
recognized that the overall shape of a small molecule is the most fundamental factor that controls its biological
effects. It is fortunate that rapid developments in asymmetric synthesis have paved the way for therapeutics to
reach the clinic. These triumphs can be attributed to the many innovations in the realms of enantioselective bond
forming processes such as asymmetric ion pairing, organocatalysis, C–H activation, Lewis acid/base, BrØnsted
acid/base, reductions/oxidations, cross-coupling reactions and many more. Despite these achievements, the
state of the art still falls short in many ways from the ideal. Although each of the unique activation modes outlined
above allow for high chemo-, diastero- and enantio-selectivities to be achieved, in many cases for the desired
bond forming event to occur the substrate must often bear a functional group that is capable of binding or being
activated by a chiral catalyst. In particular, the ability to enantioselectively convert inert C–H bonds into carbon-
carbon bonds at specific locations without the aid of directing groups is highly desirable because it would further
the drug discovery process.
To address this challenge, our work has focused on the development of new deprotonation substitution
sequences which allow for typically untargetable positions within heterocycles to be directly functionalized.
Specifically, we have found that Lewis bases can extract Li cations from strong organolithium reagents allowing
highly basic ion pairs to be produced and in turn for typically remote and inert C–H bonds in heterocycles to be
deprotonated. Secondly, we have developed a new class of chiral phosphine ligands that enable
enantioconvergent cross-couplings with racemic donor reagents. This proposal seeks to merge these concepts
by developing asymmetric deprotonation cross-coupling sequences that can allow for typically inaccessible
carbon centers to be functionalized. Specific goals of this proposal include: (1) the development of both
organolithium reagents and Lewis bases that when combined allow for typically inert C–H bonds in alkaloids to
be deprotonated; (2) the development of new chiral phosphine ligands that enable enantioconvergent Negishi
cross-coupling reactions with racemic donor reagents; and (3) the development of asymmetric deprotonation
cross-coupling sequences that allow for biologically relevant alkaloids to be directly functionalized in a single
synthetic operation.

Public health relevance
PROJECT NARRATIVE It can be safely argued that nitrogen heterocycles exhibit biological profiles that are essential for the treatment of human disease. Inspired by the past 60 years of organolithium chemistry and the advances in transition metal catalysis, the development of asymmetric deprotonation cross-coupling sequences is proposed. The carbon- carbon bond forming possesses described seek to address the longstanding problem of direct asymmetric func- tionalization of remote C-H bonds in various alkaloids allowing their physiochemical properties to be easily tuned.